IGF::OT::IGF SCREENING AND ASSESSMENT RESOURCES

The overall Phase II objectives include the complete development and evaluation of our comprehensive system based on the development and evaluation of the Phase I prototype. The development phase of this Phase II project will focus on expanded features and functionality.